Administrative-Core

Administrative Core Module Abstract The Administrative Core Module provides support for overall administration of Yale's Vision Research Core Program. The organizational structure includes a Program Director, an Executive Committee composed of all core module Directors and Co-Directors, quarterly meetings of all Yale Vision Research Core Investigators and an annual meeting of the External Advisory Committee. This administrative structure will ensure equal and adequate access to core facilities for all Vision Research Investigators through quarterly surveys of core function and performance, monitoring of a web-based scheduling system of core use and external evaluation via the External Advisory Committee. The ultimate goal of the administrative core is to provide infrastructure to organize and coordinate the efficient running of the entire Yale Vision Research Core Program and facilitate the research projects of all vision core investigators at Yale.